Exosomal miRNA in neuron to astroglial communication in the CNS

Summary
This diversity supplement aims to provide an opportunity for Rashed Alananzeh who meets the NIH
diversity candidate criteria, to carry out a post-Baccalaureate study in my lab. In this project, Rashed will
characterize the secretion of neuronal exosomes from either soma or axon terminals and the subsequent
internalization of neuronal exosomes into astrocytes. Although intraluminal vesicles (ILVs), precursors for
secreted exosomes, are largely localized in the somatodendritic compartment of cultured neurons, it is unknown
whether these ILVs are preferentially secreted from neuronal soma or axons in vivo, given that vesicular
secretion of neurotransmitters are predominantly released from axon terminals. By employing sciatic nerve
injection model to selectively label spinal motor neuron (SMN) exosomes and intravitreal injection to selectively
label retina ganglion cells (RGC), Rashed will specifically investigate and compare whether neuronal exosomes
are differentially released from either somatodendritic or axon terminal compartments and whether these
exosomes are also differentially taken up into surrounding astrocytes.
Understanding the predominant location of exosome secretion from such a polarized cell type as neurons
will give important insights into the potential function of those exosomes. By carrying out this project, it will give
him the opportunity to understand how to see a project through from conception to finish, learn various injection
techniques, deal with the troubleshooting and optimization that are always needed in scientific experiments and
learn the best ways to analyze images and data. Overall, this diversity supplement award will greatly prepare
Rashed for his research career development.

Public health relevance
Narrative This diversity supplement aims to provide an opportunity for Rashed Alananzeh who meets the NIH diversity candidate criteria, to carry out a post-Baccalaureate study in my lab. Rashed will specifically investigate and compare whether neuronal exosomes are differentially released from either somatodendritic or axon terminal compartments and whether these exosomes are also differentially taken up into surrounding astrocytes. This study will provide new insights about the functions of compartmentalized exosomes.